Structural and functional studies of the mycobacterial transcription cycle

Tuberculosis (TB), caused by Mycobacterium tuberculosis (Mtb), is an ongoing global health crisis. The WHO
reports 10 million active cases and over 1.5 million deaths annually. RNA polymerase (RNAP), the enzyme
responsible for all transcription in bacteria, is the target for rifampicin, a first-line treatment for TB. RNAP is thus
a proven and attractive target for developing new drugs. These facts highlight the importance of our recent
structural and functional characterization of Mtb RNAP, and the essential transcription factors required for full
transcriptional activity and intrinsic antibiotic resistance. In addition, we have found that studying diverse clades
of bacteria deepens our understanding of general principles of transcription. Therefore, we study Actinobacteria,
as the biophysical and molecular mechanisms of transcription in this clade are relatively understudied and
because it includes important pathogens.
We determined high-resolution cryo-EM structures of several Mtb initiation transcription complexes with essential
transcription factors and important antibiotics in the previous funding period. Here my vision is to complete the
characterization of initiation regulation and expand our focus to the post-initiation steps throughout the
transcription cycle. These steps include elongation, pausing (a regulatory step where the RNAP temporarily halts
at specific sequences, permitting input from diverse signals), and termination. We will also continue
characterizing new RNAP inhibitors.
To complete our understanding of initiation, we will continue our studies of the WhiB factors, focusing on the
essential factor WhiB1, which is required for Mtb viability and response to stress. To characterize post-initiation
steps, we plan to study the mechanisms of mycobacterial NusA and NusG. NusG in Mycobacteria increases
transcriptional pausing and termination, yet it suppresses both in the well-characterized E. coli. This difference
in activity emphasizes the need to study these factors in other clades of bacteria. Most of these studies will
involve single-particle cryo-EM, but we plan to extend our studies in situ by using cryo-electron tomography to
investigate cellular processes and organizations, such as ribosomal coupling to RNAP. To rigorously study how
transcription factors act genome-wide, we will finish developing cell-free genomics: using genomic DNA as a
substrate for purified RNAP and transcription factors, and quantifying resultant transcripts with RNA-seq. This
method is necessary to identify native DNA sequences regulated by essential factors WhiB1, NusA, and NusG,
whose regulons have remained elusive due to pleiotropy upon perturbation in cells.
In sum, I envision using a multidisciplinary approach that includes structural, genetic, biochemical, genomic, and
in situ experiments to understand the roles and mechanisms of each step in the transcription cycle and how they
are regulated by cis and trans-acting elements. The results from this proposal have the potential to elucidate the
molecular and biological mechanisms of the entire transcription cycle.

Public health relevance
Project Narrative We propose to characterize the transcription cycle structurally and functionally in the actinobacteria phylum, focusing on the pathogen Mycobacterium tuberculosis. RNA polymerase, the central enzyme of transcription, is a proven target for antimicrobials, and regulators of the transcription cycle are often clade-specific but essential for viability and virulence. Understanding how these factors regulate Mycobacterium tuberculosis RNA polymerase informs us on unified and clade-specific mechanisms, providing a more comprehensive understanding of the transcription cycle that can lead to new therapeutics against specific bacterial pathogens.